BLR&D Research Career Scientist Award Application

Project summary:
My current research is focused on understanding mechanisms by which breast cancer initiates and
progresses. While many studies on breast cancer progression are focused on cancer cell biology, we are
evaluating breast cancer as a systemic disease that influences the function of multiple organs. Breast cancer-
associated deaths are not simply due to metastasis of cancer cells to distant organs or resistance to treatment
but also due to its deleterious effects of cancer on bone and skeletal muscle. Unlike lung and pancreatic
cancers where cancer leads to debilitating weight loss and clinical appearance of cachexia, physical
appearance of most breast cancer patients remains “normal”. However, loss of skeletal muscle mass without
overt loss of body weight is very common and this loss of muscle mass is associated with poor outcome. In our
VA funded study, we are molecularly dissecting cancer-associated skeletal muscle changes, developing
biomarkers of skeletal muscle changes for early detection of cancer-induced systemic effects, and therapeutic
modalities to limit the effects of cancer on skeletal muscle. These studies are extended to other cancers
including bladder, lung, pancreatic, and head and neck cancers. We observed specific molecular differences in
skeletal muscle of men and women with the same type of cancers. Thus, there are sex-dependent differences
in cancer progression pathways, which are being explored to develop therapies that may be applicable to men
with cancer. Since 11% of patients treated at VA are cancer survivors, our studies have important implications
in improving health care at VA.
Additional studies in the laboratory are on 1) mechanisms associated with breast cancer metastasis
and therapeutic resistance; 2) genetic ancestry-dependent variability in the normal breast biology; 3) defining
cell-of-origin of breast cancer using single cell genomics, 4) the impact of exposure to extraphysiologic oxygen
on normal and cancer stem cells; and 5) developing chemoprevention strategies by understanding earliest
events in breast cancer initiation. These studies have no overlap with VA-funded studies and funded by
independent agencies. Goals of these ongoing efforts are to comprehensively understand breast cancer
development and progression and to further contribute to individualizing breast cancer characterization and
treatment. We aim to develop methods to classify breast cancer based on cell-of-origin and explore therapeutic
modalities based on genomic aberrations. Our study on the effects of extraphysiologic oxygen is expected to
change the method of tissue collection for biomarker discovery. The laboratory has been very productive over
the years with 29 publications since 2015 including two recent co-author publications in prestigious journals
Nature and Nature Communications and several senior author publications in journals such as Cancer
Research. Our publications have received more than 15,100 citations with H-factor of 62. The institutional
infrastructure, both at IU and VA, and collaborations within and outside the institution and continuous
extramural funding for the past 23 years enabled us to achieve these goals.
In addition to research, I have been involved in mentoring junior faculty, post-doctoral fellows, graduate
students, medical students, high school students, and high school teacher summer research for the past 23
years (>50 mentees). I served/serve in various grant review committees at national and international levels and
serve as an editor of prestigious journals such as Cancer Research. Since 2015, I have given 37 invited
lectures at national and international venues highlighting the significance and recognition of our research.

Public health relevance
Approximately 11% of patients of VA are cancer survivors. Quality of life is a major issue for these patients including potential loss of independence. Many patients experience weakness in muscle either due to the effects of cancer or due to the effects of treatment. Loss of muscle in cancer patients is not simply due to poor nutrition and has so far proven irreversible. Therefore, effective therapies to restore muscle function will not only improve quality of life but will consequently prolong life. Our VA funded study examines molecular changes in skeletal muscle in breast cancer and develops biomarkers and therapies to overcome muscle defects. Knowledge gained from these studies is being applied to other cancers such as lung, pancreatic, bladder, and head and neck cancers. During this process, we learnt that men and women with the same type of cancer show differences in skeletal muscle biology paving the way for individualizing symptom management that considers sex of the patient as a variable factor.